Spatiotemporal dynamics of self-organizing protein complexes through a computational lens

Project Summary
Protein complexes are organized structures composed of hundreds to thousands of copies of one to a few
types of proteins. Nature has evolved these protein complexes as a means to create biological machines with
diverse cellular functions, including those critical to human health. To date, the organizing principles for protein
complexes have focused on hierarchically-evolving spatial organization and the challenge is to extend this
framework towards inherently dynamic complexes with structures and functions that vary in time, often in
response to environmental signals. The goal of my research program and this MIRA proposal is to investigate
the structure-dynamics-function relationships that regulate the biogenesis of protein complexes with a current
emphasis on proteinaceous organelles and envelopes. Here, we specifically target two families of bacterial
proteins – S-layers and microcompartments – that will serve as excellent model systems to further our
fundamental understanding of the spatiotemporal organization of protein complexes. Our work will address two
challenging paradigms: (i) complexity due to large combinatorial space (from many types of interacting
proteins) and (ii) complexity due to large conformational space (from many protein domains bound by flexible
linkers). Our approach is to develop and to apply new computational models, simulation strategies, and
analysis frameworks that will make the study of these systems tractable. Our findings will have substantive
impact on the broader understanding of bacterial biogenesis, and in the long term, can be applied to develop
new therapeutics that target pathogenic bacteria, adapted to study dynamic protein complexes relevant to
disease progression, and repurposed to aid synthetic biology efforts for protein-based biotechnology.

Public health relevance
Project Narrative Nature has evolved self-organizing protein complexes that can change structure and function in response to the needs of the cell. The major focus of this work is to investigate the spatiotemporal organizing principles that regulate model protein complexes found in bacteria through the development and application of multiscale computational methods. The findings from this work will advance fundamental knowledge of protein complex biogenesis, create complementary computational tools, and provide potential new avenues for therapeutics that target pathogenic bacteria.